Selective Killing of FH-/- Cancer Cells by Targeting Cellular Iron Homeostasis

Hereditary leiomyomatosis and renal cell cancer (HLRCC) is an autosomal dominant hereditary cancer
syndrome caused by a germline inactivating mutation in one of the alleles of the gene encoding the
tricarboxylic acid (TCA) cycle enzyme, fumarate hydratase (FH). HLRCC patients are predisposed to develop
aggressive papillary renal cell carcinoma type 2 (PRCC2) at an early age. The cancer tissues exhibit a loss-of-
heterozygosity at the FH locus, indicating biallelic FH inactivation (FH-/-) as a critical event in tumorigenesis.
These tumors often metastasize early, limiting the effectiveness of surgical intervention. Moreover, the tumors
are resistant to all known chemo, targeted, and radio therapies, making PRCC2 a major cause of death among
HLRCC patients. Therefore, a treatment strategy against HLRCC is urgently needed.
FH-/- imparts very specific changes to the cancer cells. Particularly, FH-/- cancer cells accumulate high level of
the TCA cycle intermediate, fumarate, which alters cellular signaling in very specific ways. Identifying these FH-
/- specific cellular changes will therefore offer ways to target the FH-/- cancer cells, while sparing normal cell.
This application exploits a FH-/--specific vulnerability that we discovered recently. Specifically, FH-/- alters
cellular iron signaling, making the cells sensitive to an iron dependent cell death mechanism known as
ferroptosis. We hypothesized that ferritin inhibition in FH-/- cancer cells will further enhance their
sensitivity to ferroptosis while concurrently inhibiting the ferritin-dependent pro-proliferative signaling.
We will test our hypothesis through the following aims: (1) Define and compare pathway alterations induced by
different methods of ferritin inhibition in FH-/- cancer cells. (2) Evaluate the efficacy of combining ferritin
inhibition with ferroptosis inducing compounds (FINS) in vitro and confirm their mechanisms of action. (3)
Validate the efficacy of combining ferritin inhibition with FINS in vivo. Insights gained from this study will
positively impact the treatment of other ferroptosis sensitive tumors.

Public health relevance
This project investigates the feasibility and mechanisms of action of a novel rational drugs combination that can specifically target FH-/- cancer cells while sparing normal cells. This drug combination enhances FH-/- cancer cells’ sensitivity to a cell death mechanism that is dependent on redox active iron. Therefore, findings resulting from the proposed studies will lead to the future development of therapeutics that is effective against tumors with FH mutation and other ferroptosis sensitive tumors.